Biospecimen Core

PROJECT SUMMARY – BIOSPECIMEN CORE (CORE C)
Acquisition and characterization of biospecimens linked with clinical data and the development of
patient­ relevant preclinical models, are essential components for effective and impactful translational
research. The Dana Farber/ Harvard Cancer Center (DF/HCC) Prostate SPORE Biospecimen Core (Core
C) will maintain and expand a mature prostate cancer biorepository, including blood and tissue specimens,
from a diverse group of prostate cancer patients across DF/HCC who have provided consent to our clinical
database and biobank protocols. Core C will provide tissue specimens and vast pathology expertise to
SPORE investigators including the evaluation of both human and mouse model tissues. Core C will
maintain a database of clinical data on all consented patients, linked with standardized pathology review
procedures and data collection. Core C will work closely with SPORE investigators and collaborators to
provide interpretative and consultative pathology services, including state­of­the­art molecular assays
and imaging technologies developed at DF/HCC. Centralization of Core activities builds upon
established infrastructure but does not replicate existing resources within the DF/HCC. Overall, Core C
will greatly facilitate and accelerate translational research within the DF/HCC Prostate SPORE through
the collection and integration of highly annotated biological material and associated clinical information.